Development and application of subnational measles incidence and mortality estimates in high burden and incidence settings

Project Summary/Abstract
Vaccination against measles has been available for decades, although still a substantial number of global
cases and deaths persist. Strategies to reach measles elimination goals require a more comprehensive
understanding of the patterns of immunity and burden across space, time and age in local contexts throughout
the world, particularly in low- and middle-income countries. These challenges, in part, can be addressed via a
thorough examination of all available data on measles immunity, cases, and deaths and synthesizing these
data streams through the development of novel mathematical and statistical models, particularly on
subnational scales. This proposal will first quantify global measles immunity patterns via a systematic search of
all available seroprevalence studies and catalytic modeling to describe patterns by location and age. Next, we
will estimate subnational measles incidence in the six highest burden countries using case notifications,
serology data, and subnational vaccine coverage estimates. Then, to assess local areas with highest measles
mortality, we will estimate subnational case-fatality using all available literature and spatially available
covariates. Finally, we will assess the economic and health benefits of subnationally-targeted immunization
strategies over a nationally based approach.
This project will investigate global measles immunity and mortality patterns at national and subnational scales,
as well as evaluate the cost-effectiveness of subnational targeting of various vaccination strategies. The goal
of this research is to provide empirical evidence for global stakeholders and local decision makers to plan
informed immunization efforts as well as measles control and elimination programing. After the completion of
this research and training fellowship, the applicant will have acquired advanced skills in spatiotemporal and
statistical modeling, infectious disease and vaccination epidemiology, economic evaluation, scientific
communication, and classroom teaching. The applicant seeks expertise in these fields in order to advance
measles eradication and control efforts and to improve the overall understanding the role of subnational
analyses and estimates in optimizing disease control and local health initiatives. A multidisciplinary and
collaborative team will mentor and guide the applicant in research and training and assist in preparing the
applicant for an academic career in infectious disease and vaccine epidemiology and mathematical modeling,
with a focus on producing timely and policy-relevant research.

Public health relevance
Project Narrative Measles, a vaccine-preventable infection, is still a leading cause of morbidity and mortality, particularly among children living in Ethiopia, Pakistan, India, Nigeria, Indonesia, and the Democratic Republic of the Congo. An improved understanding of the spatiotemporal distribution of measles burden and pockets of susceptibility is required for optimal disease control and elimination efforts. Through the proposed aims, we will identify gaps in measles immunity and subnational areas impacted by highest incidence and mortality and evaluate the benefit of subnational targeting of vaccination resources.